Program Enhancement Core

The Program Enhancement Core is the administrative arm of the Oklahoma Nathan Shock Aging Center
and will oversee all activities conducted by the Center at the University of Oklahoma Health Sciences Center,
the Oklahoma Medical Research Foundation, and the Oklahoma City VA Medical Center. The Core will
promote/publicize the services of the Research Cores as well as evaluate their performance. The Program
Enhancement Core will also administer two novel programs: an annual Oklahoma GeroScience Symposium
and the Geropatholgy Research Resource. The specific aims of the Program Enhancement Core are:
Aim 1. To provide administrative/management support for the Center. The Core will be responsible for the
day-to-day management of the center; will oversee budgets, including cost recovery for the Research Cores;
and will promote the integration of services among the Research Cores. In addition, the Program Enrichment
Core will evaluate the progress or the Center in two ways: an Internal Advisory Committee consisting of
administrators and research leaders at the three host institutions that will annually evaluate the Center and the
External Advisory Committee consisting of five leaders in aging who will evaluate the Center every other year .
Aim 2. To promote/publicize services and activities provided by the Cores. The Core will be responsible for
making the scientific community aware of services provided by the Research Cores through a series of
mechanisms, e.g., a website, the Shock Centers Coordinating Center with the American Federation for Aging
Research, and Core Leaders attending aging meetings such as the Gordon and Keystone Conferences and
the annual meetings of the American Aging Association and Gerontological Society of America.
Aim 3. To provide the intellectual and organizational leadership to stimulate interest in aging and
geroscience in Oklahoma and the nation. Interest in aging and geroscience in Oklahoma City and Oklahoma
as well as the nation will be stimulated through a variety of activities, e.g., organizing a seminar series in aging
at OUHSC/OMRF, hosting the Summer Training Course in Experimental Aging Research when it is in
Oklahoma City, and participating in the bi-annual Nathan Shock Summits at the annual meeting of the
American Aging Association. Most important will be the annual Oklahoma GeroScience Symposium, which will
be organized and managed by the Program Enhancement Core.
Aim 4. To provide investigators with pathological analysis specifically designed for studying aging mice
through the Geropathology Research Resource (GRR). The GRR will provide investigators with the unique
geropathological analysis developed by the Geropathology Research Network, which will allow investogators
to evaluate the effect of age and aging interventions on the pathological status of mice. The GRR will also
collaborate with the University of Washington Shock Center to continue the functions of the Geropathology
Research Network and promote the use of the Geropathology Grading Platform to veterinary pathologists.